Bone Health in Older Ugandan Women with and without HIV

Project Summary/Abstract
The Johns Hopkins University-Uganda Clinical Trial Unit (JHU-CTU) has been at the
forefront of clinical trial research as part of the DAIDS funded HIV network studies with a goal of
developing effective and safe interventions for both HIV prevention and treatment in resource
limited settings. For this cycle (2020-2027), the JHU-CTU with its two Ugandan research sites,
aims to evaluate new antiretroviral treatment and prevention regimens, novel delivery systems
and/or novel immune-based therapy for prevention among at risk women and adolescents; and
for treatment of HIV-infected pregnant women, adolescents and children. The CTU aims also
address prevention and treatment of HIV coinfections including TB and HBV; and studies of
vaccines for emerging infections. As a further aim, the JHU-CTU continues its commitment to
mentor and develop international investigators to become leaders in conducting HIV research.
This administrative supplement falls within the JHU Uganda CTU aim addressing the safety,
(short and long term) of ARVs used for both HIV prevention and treatment in resource-limited
settings such as Uganda. As ARVs may have different safety profiles in differing racial/ethnic
groups, it is important to use appropriate normal values to assess ARV safety across diverse
populations; and if there are differences in safety profile by sex, age and race/ethnicity.
Tenofovir-based ART (TDF-AFT) for example is known to be associated with decreased bone
mineral density (BMD) during the first year of treatment. However, little is known on later effects
of lifetime TDF-ART in international populations including among post-menopausal women and
if they are at increased risk for osteoporosis and bone fracture compared to older HIV negative
women. And BMD “normal values” for older HIV negative African women are not available.
Thus, for this administrative supplement, the JHU CTU MU-JHU clinical research site (CRS)
aims to assess and compare (BMD) and body composition among older women with HIV on
lifetime ART, to BMD results among HIV negative Ugandan women of similar age. MU-JHU will
recruit 236 women (both HIV infected and HIV negative) age 40-60+ years from the AFRICOS
cohort in Kayunga, Uganda to perform DXA imaging scans and bone health lab studies. Data
from this cross-sectional analysis will be used to: (1) compare BMD in Ugandan women living
with HIV and HIV-uninfected women, (2) examine body composition (i.e., visceral adiposity and
BMI) in these two groups, and (3) analyze the distribution of BMD for comparison to standard
population-based cohorts. This study will collect valuable normative data on BMD and safety
data on fracture risk among older women of African origin, including those living in the U.S.

Public health relevance
This administrative supplement proposal to the JHU Uganda CTU grant will address bone health among perimenopausal and post menopausal East African women living in Uganda; utilizing measures of bone mineral density (BMD) and body fat composition as measured by DXA scans, and bone lab assays (Calcium and Phosphorus). The aims of the study are to compare BMD among older (40 years+) Ugandan women who are living with HIV, with findings among HIV negative women of similar age and sociocultural background; to assess risk factors associated with lower BMD measures including women living with HIV who are on tenofovir- based antiretroviral treatment regimens; and to compare findings with the US based norms as well as BMD results from other diverse study groups. The findings will help inform measures of bone health among African born women living in the US, including diagnosis and treatment of osteopenia/osteoporosis based on assessing “normal values” of BMD relevant to this racial minority living in the US.